Motor cortical circuitry adaptations in experimental Parkinson's disease

Parkinson’s disease (PD) is the second most common neurodegenerative disease of aging and as such it
associates with a rapidly growing socioeconomic burden. A hallmark of PD is the loss of dopaminergic (DA)
neurons in the substantia nigra, which is causally linked to the debilitating motor symptoms that characterize
this disease. However, motor function is not confined to the substantia nigra –other brain structures, like the
primary motor cortex (M1) that controls specific sets of motor skills, are affected in PD. Until recently, the
abnormal activity of M1 neurons observed in PD was thought to be a direct consequence of an increased basal
ganglia inhibition due to the loss of nigral DA neurons. There is now strong evidence indicating that M1 circuitry
exhibits adaptive changes in response to loss of DA neurons. Our preliminary data show numerous intrinsic
and synaptic adaptations in M1 circuitry. Yet, we lack fundamental understanding of M1 circuitry dysfunction in
PD in the context of its neuronal heterogeneity and synaptic complexity.
In the proposed research, we will systematically study how the loss of nigral DA neurons induces adaptative
changes in the intrinsic properties of pyramidal neuron subtypes in the layer 5 of M1. We will also determine
molecular and ionic mechanisms that associate with these changes (Aim 1). A combination of ex vivo patchclamp recording with pharmacological and biophysical approaches will be used to address these two
questions. Moreover, by combining ex vivo patch-clamp recording with optogenetics, chemogenetics, and
connectomics, how the loss of nigral DA neurons alters the connection strength and plasticity of
thalamocortical synapses will be determined (Aim 2). Last, the time course of M1 circuitry dysfunction as
neurodegeneration occurs will be studied using a mouse model that shows progressive loss of nigral DA
neurons and levodopa-responsive motor deficits. In these studies, M1 circuitry dysfunction will be related to the
basal ganglia dysfunction and development of motor deficits to determine its role in the onset and progression
of motor dysfunction (Aim 3).
The information arising from the proposed research will fill the gap in knowledge regarding M1 circuitry
dysfunction associated with the loss of nigral DA neurons. This knowledge will aid the identification of novel
physiological biomarkers for PD progression and the design of noninvasive approaches targeting M1 for
treatment of PD.

Public health relevance
PROJECT NARRATIVE The proposed research aims to study the intrinsic and synaptic adaptations of pyramidal neurons in the layer V of the primary motor cortex using experimental models of Parkinson’s disease (PD). With this research, we will gain mechanistic understanding of the aberrant motor cortical activity seen in individuals afflicted by PD, providing critical insight into PD’s pathophysiology that can help us to improve the treatment of this devastating disease. Therefore, this research is relevant to the missions of the NIH and the NINDS.